COLLABORATIVE PERINATAL PROJECT IN OBESITY GENOME-WIDE ASSOCIATION STUDIES

Obesity is a complex multi-factorial condition that results from genetic predisposition and lifestyle factors such as high energy food consumption and physical inactivity. The heritability of childhood BMI has been estimated to be 40-70%. The high heritability of obesity in the context of the current obesogenic environment strongly suggests that genetic factors are implicated in population patterns of obesity and, are essential to consider in population approaches to address the obesity epidemic.
Identifying genetic factors that influence early childhood BMI can inform the etiology of obesity as well as help to identify strategies to prevent and treat childhood obesity and related adult cardiometabolic diseases. Currently, the genetic factors that influence early childhood BMI are not well understood. Genome-wide association studies (GWAS) could help identify these genetic factors and distinguish their effects across ages.
The Collaborative Perinatal Project (CPP) was a prospective pregnancy cohort that enrolled women who had prenatal care at 12 medical centers in the United States from 1959-1965. Women were followed from early pregnancy onwards and their offspring were monitored from birth through 7 years of age. While the CPP enrolled children prior to the obesity epidemic and obesogenic lifestyle in the United States, any potential interactions
between genetic factors discovered using this cohort and recent environmental modifiers can be validated using other more recent cohorts. The CPP offers opportunities to discover novel genetic loci related to obesity among Africans and Europeans and to improve the functional characterization of known loci discovered in European populations.
The primary aims of this study are to identify genetic influences on growth and obesityrelated phenotypes during neonatal, infancy and early childhood periods among children in the CPP cohort (n= 10200; 5100 African American and 5100 European American), and to identify trans-ancestral and ancestry-specific genetic loci associated with BMI at 7 time points from birth to 7 years of age (birth, 4 months, 8 months, 12 months, 3 years, 4 years, 7 years) via trans-ancestry GWAS.
The feasibility of this project was determined in a previous pilot Task Order. The Contractor shall receive the samples over a period of approximately 8 months, with the first shipment of samples providing ample material to confirm the pilot results and standardize procedures. Samples shall arrive in their original vials, with an expectation of approximately 1 milliliter of volume per sample. The Contractor shall aliquot the volume needed for the DNA extraction and transfer any remaining volume into a new, barcoded